A Mobile Health Behavior Intervention to Reduce Pain and Improve Health-III (MORPH-III)

PROJECT SUMMARY
As many as three in four older adults live with chronic pain; a debilitating condition that affects quality of life
and independence. Unfortunately, chronic pain both affects and is affected by low levels of physical activity,
excess sustained sedentary time, weight gain, and isolation. Across Stage Ia and Ib pilot trials, we have
demonstrated the feasibility, acceptability, and potential benefit of a remote group-mediated behavioral
intervention rooted in social cognitive and self-determination theories that targets dietary weight loss via caloric
restriction and both increased physical activity and decreased sitting via the accumulation of steps in frequent
bouts throughout the day (daylong physical activity). Limitations of previous research include: short duration
(12 weeks), small samples (up to 44 participants per study), and the inclusion of heterogeneous pain sites. The
primary purpose of this Stage II R01 is to test the efficacy of 6 months of a remotely delivered group-mediated
weight loss+daylong movement on daily steps (primary outcome), pain interference (secondary outcome), body
weight, pain intensity, quality of life, and key psychosocial antecedents of behavior change in older adults with
chronic knee or hip osteoarthritic pain. We will also explore for effects on long-term behavior change over 12
months following the intervention. We propose to randomize low-active older adults with chronic osteoarthritic
pain and obesity to the weight loss+daylong physical activity intervention or to an enhanced usual care control.
These individuals will receive the same self-monitoring technologies as the intervention condition to account for
any effect of basic device provision on activity and diet behavior. The results of this trial will inform future real-
world efficacy and effectiveness trials of a package well-suited to broad scale delivery.

Public health relevance
PROJECT NARRATIVE Chronic pain is a common experience for many older adults, and it powerfully affects a person’s ability to live independently and with a high quality of life. This project will investigate whether an in-home program informed by psychology and involving increasing physical activity while sitting less, bonding with a group of peers, and reducing body weight can help to improve the physical activity levels and pain symptoms of older adults living with chronic pain. Our long-range goal is to develop a scalable and accessible program that can improve pain symptoms of many older adults at home.